ROLE OF ESTROGEN IN MODULATING PTH INDUCED CYTOKINE RELEASE

The primary objective of this study is to assess the role of estrogen in modulating parathyroid hormone (PTH) induced cytokine release, most notably IL-6. We wish to determine in this study whether in vivo, in humans, estrogen withdrawal is associated with an increased release of IL-6 in response to PTH which may, in part, explain the increased bone loss that occurs in the years after menopause.